3D Genome Reorganization and Epigenome Dynamics of Clonal Hematopoiesis

PROJECT SUMMARY
Clonal hematopoiesis (CH) commonly occurs with aging and is associated with increased mortality, a higher risk
of leukemia, and cardiovascular disease. As the population of older adults expands in the US, there is an urgent
unmet need to mitigate CH. Age-related CH is the abnormal expansion of hematopoietic cells that have somatic
mutations, mostly in genes encoding the DNA methyltransferase DNMT3A and the demethylase TET2. These
'CH-mutations' change the hematopoietic stem cell (HSC) epigenome (i.e., DNA methylation and chromatin
accessibility) at promoters and enhancers. To better understand how these changes impact gene regulation to
confer a competitive advantage to a subset of HSCs and contribute to CH development, we propose a multi-
omics approach that considers the effects of epigenomic changes on the physical interactions between
enhancers and promoters, which are critical to activating transcription. By mapping the genome's 3D chromatin
interactions, we will identify the specific enhancer-promoter pairs that control key HSC cellular functions such as
self-renewal and response to inflammation. Although it is known that the epigenome organization of HSCs
changes with age, it remains unclear how aging and CH-mutations jointly remodel the '3D epigenome' (3D
chromatin organization and epigenome) of HSCs and contribute to CH. Our central hypothesis is that the 3D
epigenome is remodeled with age and impacts transcriptional programs critical for HSC function. Thus, to identify
therapeutic targets for elongating healthspan and delaying or preventing the occurrence of CH-associated
disease in the aging US population, this proposal seeks to systematically uncover the 3D epigenomic
configurations of cellular competition in CH and to prioritize candidate gene targets that emerge in early aging.
Using mouse models of CH and human primary cells, we will test this hypothesis via bulk and single-cell multi-
omics mapping (including RNA-seq, chromatin accessibility, and chromatin interactions) of normal and mutant
HSCs to systematically determine their 3D epigenome remodeling during early aging. In Aim 1, we will determine
whether 3D epigenome organization is linked to an aging transcriptional program in mouse and human HSCs by
identifying and integrating HSC-specific 3D genomic, epigenomic, and transcriptomic signatures from young,
middle-age, and old individuals of both species and validate the roles of top candidate genes in HSC aging in
vivo. In Aim 2, we will define age-dependent 3D epigenome remodeling in HSCs of CH mouse models and
validate the roles of top candidate genes in clonal expansion of mutant HSCs in vivo. Aging signatures that
emerge at middle age will likely be the initial cause of functional changes in aged HSCs. Thus, the study will
reveal primary and modifiable targets for therapeutic intervention. In Aim 3, we will determine the response of
CH-associated chromatin reorganization in aged HSCs to epigenetic therapy and anti-inflammatory drugs in
vivo. We anticipate that the findings from this study will accelerate the development of early interventions to
preempt CH-associated disease in aging individuals.

Public health relevance
PROJECT NARRATIVE As people age, their blood stem cells can develop mutations that increase their proliferation and result in a higher risk of developing blood cancer and cardiovascular disease. However, since the impact of these mutations on gene expression in aged blood stem cells is poorly understood, we currently have no clinical strategies to prevent increased proliferation of blood stem cells during aging. By fully defining the key molecular features of mutated blood stem cells that change with age, this study will support the development of new therapies to prevent blood stem cell over-proliferation and thereby improve the healthspan of aging individuals.